Planning for Prevention of Parkinson's disease: A Trial Design Forum

Project summary/ abstract:
The proposed conference project will be centered on the “Planning for Parkinson’s
Prevention: A trial design forum”, held October 2nd to 3rd, 2022. The overall long-term
objectives of this R13 program are to foster the education, training, and future research
of investigators in the emerging translational and clinical neuroscience theme of
preventative therapeutics for Parkinson’s disease (PD); and to further early initiatives
and trial efforts in PD prevention. These project objectives will be achieved through
three specific aims (SAs). SA #1 is to provide an update on current research in
prevention trial development with a focus on the critical trial design elements (via
symposium sessions), and to share and compare emerging clinical trial protocols and
initiatives (via presentations and discussion in an interactive session). The symposium
portion of the forum will cover i) whom to enroll (genetically and prodromally at-risk
populations), ii) what interventions to test, and iii) how to measure prevention of PD or
its progression prior to diagnosis (e.g., with biomarker or clinical assessments). SA #2 is
to increase research community engagement by enlisting at-risk advocates, providing a
hybrid conference format, and publicizing our forum widely. SA #3 is to provide
additional training in prevention therapeutics and facilitate networking opportunities for
early career investigators through creation of an educational curriculum.

Public health relevance
Project Narrative: Fostering the education, training, and future research of investigators, along with increasing the engagement of the research community in the emerging translational and clinical neuroscience theme of preventative therapeutics for Parkinson’s disease (PD) are of critical importance given the increasing number of people affected by this progressive neurodegenerative condition. By attending the “Planning for Parkinson’s Prevention: A trial design forum”, attendees will learn about the critical design elements for prevention trials, the early initiatives and trial efforts in PD, as well as ongoing opportunities, challenges, and next steps for prevention. Attendees will be motivated to engage with, and be better prepared to design and implement rigorous clinical trials in PD prevention.